Yale Occupational and Environmental Medicine Residency Training Program

Project Summary/Abstract
The Yale Occupational and Environmental Medicine (OEM) residency training program, based
in the Department of Medicine at the Yale School of Medicine, is one of the oldest, most
productive, stable and highly regarded occupational medicine residency training programs in the
United States, training 66 OEM physicians over the past almost thirty-five years. There is an
urgent need for OEM and public health / preventive medicine (PM) trained physicians in multiple
settings across the U.S., further highlighted by the COVID-19 pandemic.
The Yale OEM residency is an integrated two-year NIOSH-funded PM / OEM residency training
program that is fully accredited by the Accreditation Council for Graduate Medical Education
(ACGME), and leads to board eligibility for certification in PM and OEM by the American Board
of Preventive Medicine as well as a Master of Public Health (MPH) Degree from the Yale School
of Public Health. The program is currently approved for a total of four positions, two per year.
Trainees admitted to the program are expected to have completed an initial ACGME accredited
residency in an appropriate clinical specialty, typically Internal Medicine or Family Medicine.
This NIOSH TPG 5-year renewal proposal describes the Yale OEM residency program.
Highlighted are: 1) our success to date in training physicians for OEM careers, 2) our current
OEM training program, which is continually evolving to meet changing needs, and 3) our plans
for training future OEM physician leaders able to address the substantial challenges U.S.
workers and employers will face in the future. The goal of Yale OEM Residency training
program is to train physicians to be proficient in all aspects of the practice of occupational and
environmental medicine, based on a sound fundamental knowledge of epidemiology, industrial
hygiene, biostatistics, toxicology, human and organization behavior, clinical medicine, and
evidence-based critical analysis. We train future physician leaders to serve in a range of OEM
academic, clinical and public health roles, with a particular focus on developing skills as
educators and scientific investigators, in preparation for successful academic careers.

Public health relevance
Narrative There is a critical shortage of physicians formally trained in occupational and environmental medicine (OEM) at a time of escalating workplace and environmental hazards and exposures, highlighted by the current COVID-19 pandemic. This NIOSH TPG proposal describes the Yale OEM residency program, a long-standing highly successful and stable ACGME-accredited NIOSH-supported PM / OEM residency training program with the goal of training future OEM physician leaders in a range of OEM academic, public service and practice careers. The training program continues to evolve to train OEM physicians to address the substantial challenges U.S. workers and employers will face in the future.